Investigating the role of gamma delta (γδ) T cells in the control of Mycobacterium tuberculosis infection

SUMMARY
Mycobacterium tuberculosis (Mtb) is the pathogenic bacteria which causes tuberculosis (TB) disease and was
responsible for 1.6 million deaths worldwide in 2021. It is well-established through human and animal studies
that alpha-beta (αβ) T cells are important for the control of Mtb infection, but the role of gamma-delta (γδ) T cells
is less well-defined. γδ T cells express T cell receptor (TCR) heterodimers comprised of a γ-chain and δ-chain
that mediate recognition of a variety of lipids or small molecules presented by major histocompatibility-like
ligands, such as cluster of differentiation 1 (CD1) or butyrophilin molecules. There is growing evidence that γδ T
cells are important in the early protective immune response against Mtb in the lung. The central hypothesis of
this application is that γδ T cells contribute to control of Mtb infection through recognition of mycobacterial lipids
and promotion of an enhanced adaptive immune response. A subset of γδ T cells, termed Vδ1 cells, are enriched
in tissue and have known reactivity to mycobacterial lipids presented by CD1 molecules. In AIM 1 we will evaluate
the molecular mechanisms underlying Vδ1 T cell lipid antigen recognition through analysis of in vitro expanded
clones and computational analysis of lipid-specific Vδ1 TCR motifs. By investigating specific TCR motifs
governing recognition of mycobacterial lipids by Vδ1 T cells, we will determine shared TCR characteristics that
will enable their identification in clinical cohorts. A major challenge to the field has been the lack of a suitable
animal model to understand the role of γδ T cells in mediating protective immunity to Mtb. We will develop a
novel in vitro granuloma model using the palatine tonsil, a readily accessible human mucosal tissue, and
investigate the role of γδ T cells in mechanisms of bacterial control. Our preliminary data reveal that the tonsil
contains γδ T cell subsets which respond to in vitro mycobacterial infection and specialized dendritic cells subsets
that can prime T cell responses. Thus, in AIM 2 we will use tonsil cells to study γδ T cell interactions with dendritic
cells in response to mycobacterial infection and develop an in vitro granuloma model and investigate the role of
γδ T cells in granuloma organization. A tractable tonsil-based in vitro granuloma system will be an important
contribution to the field and provides a unique system to interrogate the function of γδ T cells in response to Mtb.
Together, our proposal will lead to increased understanding of γδ T cells and profile their involvement in the
protective immune response to mycobacteria.

Public health relevance
PROJECT NARRATIVE There is an urgent need for a better vaccine to combat the global threat of Tuberculosis. Gamma delta (γδ) T cells, which can recognize mycobacterial lipids and interact with diverse cell types to initiate a protective response, are an interesting target for vaccination. In this proposal, we will use advanced computational techniques and novel in vitro systems to analyze mechanisms used by γδ T cells to promote control of Mtb infection, which will inform future vaccination efforts.